Developing an Intervention to Optimize Virtual Care Adoption for COPD Management

Background: VA is a leader in virtual care (VC), a term that covers over 60 patient- and team-facing mobile
applications, an online patient portal, and numerous telehealth services. There is incredible potential for VC to
support chronic disease management, such as that for chronic obstructive pulmonary disease (COPD). COPD
is a leading cause of mortality and substantially more prevalent in Veterans than civilians. Use of VC in COPD
has shown significant improvements in morbidity and hospitalizations. However, VC services can only support
COPD management if they are adopted. Veterans are not currently taking full advantage of the power of VC,
largely because neither patients nor the healthcare team are aware of the available options. My CDA will
develop a strategy to address this gap. This CDA will equip me with the necessary training to tackle this and
other barriers as I develop into an independent health services researcher with expertise in the development
and implementation of VC services to support chronic disease management.
Significance/Impact: As part of the MISSION Act, VA prioritizes providing “any care anywhere” and
emphasizes the value of VC in achieving this goal. This prioritization is echoed in the VA Office of Connected
Care’s 2021-2025 Strategic Plan which aims to enhance Veteran engagement with VC and empower the
workforce to deliver VC. Aligned with these priorities, the proposed study will develop and pilot an innovative,
patient-centered implementation strategy aimed at addressing patient- and healthcare team-facing barriers to
adopting VC for COPD. The proposed work will yield knowledge as to whether this strategy is feasible and
effective for engaging patients, encouraging patient-team decision making, and expanding access to VC
services for patients who want to use them. This knowledge will be transferable across other chronic conditions
by adapting the educational content pertaining to the VC services for other chronic conditions. An effective
strategy to support VC adoption has potential for enormous impact on the lives and health of Veterans.
Innovation: This is the first study to leverage VA’s Annie, a free and easily accessible short message service
(SMS) texting platform, to deliver empowering educational content to support Veterans in navigating the
multitude of VA VC services.
Specific Aims: We will generate information about barriers and facilitators healthcare team members (Aim 1)
and Veterans with COPD (Aim 2a) face regarding adoption of VC. Aim 2b will develop a multicomponent
implementation strategy, referred to as VC-OPTIONS (Virtual Care for Chronic Obstructive Pulmonary Disease
Adoption Support) to support adoption of VC for COPD management. Aim 3 will pilot the VC-OPTIONS
implementation strategy to assess feasibility and acceptability and gather preliminary effectiveness data to
inform a larger hybrid effectiveness-implementation trial.
Methodology: In Aim 1a I will administer a survey to clinical team members to understand current awareness
and use of VC and identify persons to interview in Aim 1b, which will use qualitative interviews to identify
barriers and facilitators to supporting Veteran adoption of VC. Aim 2a will identify patient-facing barriers to VC
adoption. This aim will also use a participatory design process to develop and refine educational content to be
delivered via Annie as the core component of VC-OPTIONS. Aim 2b will develop and refine the components of
VC-OPTIONS. Aim 3 will pilot the implementation strategy for feasibility and acceptability and gather
preliminary effectiveness data on VC awareness and adoption.
Next Steps/Implementation: The implementation strategy will be evaluated in a hybrid type 2 effectiveness-
implementation trial in a subsequent IIR. Findings will be communicated to VA operational partners to inform
the future of VC adoption initiatives. Knowledge from this CDA will prepare me to develop studies focused on
supporting uptake of VC in other prevalent chronic conditions and overcoming other barriers to VC adoption.

Public health relevance
VA is a leader in virtual care (VC), including the patient portal, mobile apps, and telehealth programs. VC has great utility for managing chronic conditions like chronic obstructive pulmonary disease (COPD). However, adoption of many VC services has been slow. Lack of awareness about these services is one of the most prominent patient- and healthcare team-facing barriers to adopting VC. This study will develop and refine a stakeholder-informed multicomponent implementation strategy to support adoption of VC. The core component of this strategy will be the provision of information via VA’s Annie texting program to empower patients with knowledge about the array of VC services and how they can be used to support COPD management. This work will improve patient and team awareness of and communication about VC services, and support patient access to VC services for COPD management. The proposed CDA will fill considerable gaps in my training in consumer health informatics, patient-centered communication, and implementation trial design.